Characterizing regulatory mechanisms of desmosomal protein expression in arrhythmogenic cardiomyopathy

Project Summary
Heart disease remains the leading cause of mortality in the United States and in the developed world.
Arrhythmogenic cardiomyopathy (ACM) in particular is a leading cause of sudden cardiac death in both young
people and athletes, remains difficult to diagnose, and has no currently effective treatments. ACM is termed a
disease of the desmosome, a cell-cell junctional protein complex critical to cardiomyocyte adhesion, as 40-50%
of underlying genetic mutations known to be pathologic for ACM affect a core desmosomal gene component.
Importantly, the loss or reduction of any singular desmosomal protein component at the intercalated disc is
associated with a “domino effect,” where adjacent desmosomal protein expression is lost, compromising cellular
attachment and gap junction electrical conductivity in the heart. Our hypothesis is that the dysregulation of
desmosomal protein content homeostasis is directly correlated to ACM disease progression and can be
leveraged to identify viable therapeutic targets which could be translated into patient care. Here I will employ
both molecular and theoretical approaches to screen for differential transcriptomics and proteomics related to
reduction and loss of the core desmosomal component plakophilin-2 (PKP2). In addition to these unbiased
approaches, I will leverage human induced pluripotent stem cell (iPSC) and mouse models of PKP2-mutant ACM
to characterize candidate regulatory pathways of disease progression. These models each contain distinct splice
acceptor site mutations, and have displayed sufficiency to recapitulate disease phenotypes, providing first-of-
their-kind platforms to address how RNA alternative splicing and post-transcriptional dysregulation may drive
ACM. We further show preliminary studies demonstrating that gene therapy reintroduction of the gap junction
protein connexin-43 (Cx43) rescues both early- and late- stage disease phenotypes in spite of the continued
absence of the desmosomal core component desmoplakin. Here I will assess whether Cx43 itself may serve as
a master regulator of desmosome protein content at the intercalated disc by applying Cx43 gene therapy in the
novel context of PKP2 loss, and characterize the broad applicability of this therapeutic approach. My goal for
this project is to provide a comprehensive characterization of desmosomal protein regulation across
multiple platforms, leveraging predictive systems-level computational molecular models and state-of-
the-art RNA binding protein pull-down techniques to identify essential mediators in this signaling
network, while assessing the efficacy of Cx43 candidate gene therapy in ACM rescue using
physiologically relevant tissue engineered models of human disease and in mice, to establish a
generalizable mechanistic model to treat the array of ACM disease presentations in the clinic.
Understanding common regulatory pathways controlling desmosomal protein expression at the intercalated disc
could be critical to preventing, mitigating, and treating ACM in humans.

Public health relevance
Project Narrative Cardiac arrhythmia can be an early indicator of disrupted heart cell-cell junctional integrity, which can progress to advanced stages of pathologic heart remodeling and sudden cardiac death, with early-stage disease diagnosis remaining a challenge, complicating the development of targeted therapies. It is essential to understand the regulatory mechanisms in place that control protein expression and turnover at the cardiac cell-cell junction in order to identify critical mediators of this process which could be targeted for therapeutic intervention. In the proposed research project, I will leverage molecular and computational techniques to characterize junctional protein expression regulation dynamics and assess the efficacy of a candidate gene therapy reintroduction approach in the rescue of arrhythmia and subsequent heart failure in physiologically relevant disease models with the goal of discovering generalizable regulatory pathways which could be exploited for patient care.